PROJECT 4: MOLECULAR AND CELLULAR MECHANISMS FOR THERMAL ROBUSTNESS AND MULTISEN

A robust themnosensory response in natural environments requires an animal to integrate circuits for temperature detection with circuits for other sensory modalities. The circuits for all sensory modalities must also work robustly over a range of temperatures. C elegans offers an excellent opportunity to prot)e the molecular and cellular mechanisms that regulate circuit function across different temperatures as well as mechanisms that integrate thermosensory and non-thermosensory inputs. The use of novel quantitative behavioral assays, optical neurophysiology and the rich neurogenetics available in C elegans allows us to identify and characterize the molecular, neuronal and circuit determinants of thermal robustness and multisensory integration during navigational behavior. Here, we propose to probe the interplay between thermosensory and chemosensory navigational behaviors in C elegans. The principal thermosensory neurons (AFD), NaCI-sensing neurons (ASE), and olfactory neurons for chemoattractants (AWC) are presynaptic to the same interneurons (AIY). Thus, mechanisms for multisensory integration between thermosensory and chemosensory inputs may be located in the first synapse, and moreover, the thermosensory circuit, may play a direct role in temperature-dependent regulation of the chemosensory circuit. Our proposed multifaceted analyses will uncover novel mechanisms of thermal robustness and multisensory integration, principles of which are likely to be highly conserved.

Public health relevance
Temperature modulates behavior and physiology in all animals. Therefore, robust sensory responses to thermal cues and to all sensory modalities at different temperatures are of critical for survival. C elegans provides us a model system to understand temperature sensing and compensation at molecular, cellular and circuit levels. These insights will help us to understand the pathology of several common human diseases, such as asthma and chronic pain, and to develop treatment of these disorders.